Roybal Center for Financial Decision Making

DESCRIPTION (provided by applicant): This renewal proposal for the RAND Roybal Center for Financial Decision Making will continue and expand upon the work that we have already done to improve our understanding of how people reach decisions about issues affecting their economic status in old age, and develop tools that can help people align these decisions with their long-term objectives. We will continue to develop a research program focused on how people collect and process information, how they interpret the features of alternatives, how they think about risks and probabilities, how they trade off between the present and the future, what their preferences are, and how well they match their decisions to those preferences;weak links in this process are used to draw implications for better education, information provision or other mechanisms to help people make decisions that better serve them in old age. To that end, we will maintain the American Life Panel, a panel of 1500 respondents (growing to 3000 during the first year of the project period) surveyed about bi-weekly via the Internet. In addition we will develop a Qualitative Research Facility for conducting focus groups and cognitive interviews. We will develop decision support software and extensively use visual aids and graphical designs, thus fully exploiting the advantages offered by the Internet. We will fund pilot projects with a specific substantive focus on economic status in old age and high potential translational value for policymakers, NGOs and/or commercial entities. We will also promote and coordinate research without P30 Roybal Center support on issues that may help us understand individual decision making related to economic status in old age;and promote the use of the Center's Internet panel and Qualitiative Research Facility by these and other research projects. The Roybal Center will work closely with other centers and projects to achieve maximal synergies.

Public health relevance
PUBLIC HEALTH RELEVANCE: This research project will use internet surveys, focus groups, cognitive interviews, and experiments to develop strategies that help people make better decisions related to economic well-being at older ages.